Indigenous Determinants of Prenatal Substance Use

This application, “Indigenous Determinants of Prenatal Substance Use,” proposes using photovoice
participatory action research (PAR) to identify community-defined, place-based factors that serve as
protective and risk factors influencing prenatal substance use, based on the first-person perspectives of
American Indian child-bearing adults. Drawing upon photo-based community-resonant knowledge, this
study will develop community-prioritized recommendations for prenatal behavioral health practice
strategies, contextualized by a scoping review of existing interventions developed for prenatal substance
use. This proposal responds to the RFA of “the Indigenous Trauma and Resilience Research Center
(ITRRC) Grant Program.”

This study proposes to conduct primary PAR, using photovoice techniques, and to embed a scoping
review within the investigation. The photovoice PAR—an innovative method of creating art-based,
community-based knowledge—will be conducted to identify community-defined social determinants of
health constructs of prenatal substance use among American Indian women with a recent history of
pregnancy (Aim 1). A scoping review, an effective method for evidence and gap mapping, will be
conducted to critically analyze existing interventions and prevention programs developed for American
Indian women with prenatal substance use (Aim 2). This method is particularly suited for systematically
analyzing how social, economic, and environmental characteristics are integrated as theories of change or
target mechanisms in existing interventions. This evidence synthesis will contextualize the photovoice
findings, particularly regarding practice implications and policy priority-setting, as directly recommended
by American Indian participants.